The Effects of Doxycycline on Inflammation and the Microbiome: 'Flipping the Script' on STI PEP

PROJECT SUMMARY
HIV and bacterial sexually transmitted infections (STI), including gonorrhea, chlamydia, and syphilis, are
disproportionately concentrated among men who have sex with men (MSM) and transgender women (TGW).
Doxycycline post-exposure prophylaxis (doxy-PEP) taken as a single 200mg dose <72 hours after sex is a new
intervention that can significantly reduce the risk of bacterial STI including a >70-80% reduction in chlamydia
and syphilis and >50% reduction in gonorrhea among MSM and TGW with and without HIV. However,
significant concerns remain about the potential for substantial harms associated with increased use of doxy-
PEP including antimicrobial resistance and effects on the microbiome that could influence long-term acquisition
of comorbidities, such as obesity. However, absent from the conversation on the risks/benefits of doxy-PEP to
date are the known direct anti-inflammatory and immunomodulatory effects of doxycycline, independent of its
antimicrobial effects. Among people with HIV (PWH), chronic inflammation, in part mediated by damage to the
gut mucosa and microbial translocation, is thought to contribute to increased morbidity through accelerated
acquisition of comorbidities. Our group has previously characterized the altered gut immune environment
among MSM with HIV and the contribution of bacterial STI to rectal mucosal inflammation and perturbations in
the microbiome among MSM with HIV. In addition, our group has extensively characterized a pro-inflammatory
rectal mucosal immune environment among MSM without HIV engaging in receptive anal intercourse that may
be associated with HIV acquisition. Given the critical role that inflammation likely plays for MSM both with and
without HIV, the potential for anti-inflammatory effects of doxy-PEP, and our preliminary data suggesting
minimal effect of doxy-PEP on the gut microbiome, this begs the provocative hypothesis: Could doxy-PEP play
a beneficial role in reducing systemic and gut inflammation with minimal harmful effects on the gut microbiome
and resistome among MSM and TGW with and without HIV? To address our hypothesis, we will enroll a
mechanistic clinical trial of MSM and TGW (n=75 with HIV on antiretroviral therapy; n= 75 without HIV on pre-
exposure prophylaxis) and randomize 2:1 to take 200mg of doxycycline at least 3 times/week for 12 weeks vs.
observation with biologic sampling. We will sample blood and rectal mucosal secretions and tissues before and
after doxy-PEP use that will allow us to fully characterize the effects on systemic (specific aim 1) and rectal
mucosal (specific aim 2) inflammation and the microbiome and resistome (specific aim 3) at high resolution
and determine whether we can ‘flip the script’ on the potential harms of doxy-PEP for this high need population.
Completion of the proposed aims will allow for a comprehensive assessment of the anti-inflammatory and
microbiome/resistome effects of doxy-PEP and could ameliorate concerns for widespread implementation of
this new intervention.

Public health relevance
PROJECT NARRATIVE Doxycycline post-exposure prophylaxis (doxy-PEP) taken as a single 200mg dose <72 hours after sex is a new intervention that can significantly reduce the risk of bacterial sexually transmitted infections among men who have sex with men and transgender women with and without HIV; however, significant concerns remain about the potential for substantial harms associated with increased use of doxy-PEP. For this proposal, we will conduct a mechanistic clinical trial to examine the potential anti-inflammatory effects of doxy-PEP in the blood and rectal mucosa as well as define the effects on the gut microbiome and resistome. Completion of the proposed aims could validate or diminish concerns for widespread implementation of this new intervention.